EFFECT OF CYTOKINES IN HOST DEFENSE AND INFLAMMATION

The kinetics of the appearance of cytokines and mediators of inflammation was determined in normal subjects and in selected patients with abnormal host defense. For this study a model of inflammation in the skin was employed using a blister device. In normal subjects C5a, LTB4, and gamma-interferon appeared within 3 h of raising blisters, Il-8 and Il-6 appeared from 8 through 24 h and Ill-B, GM-CSF and TNF-alpha appeared from 12 to 24 h. In vitro studies indicated that exudate neutrophils are capable of TNF-alpha. production. Studies in patients with chronic granulomatous disease revealed normal mediator accumulation in these patients. In contrast, patients with the hyperimmunoglobulin E-recurrent infection (HIE) syndrome had about ten-fold increased TNF-alpha accumulation in the blister fluid. The increased TNF-alpha was restricted to the local inflammatory response since in related studies, in which a preparation of the lipid A component of E. coli endotoxin was administered intravenously to normal volunteers and HIE subjects, normal increases in TNF-alpha, Il-8 and Il-6 in the circulation in HIE subjects was observed. Abnormal regulation of TNF-alpha at local inflammatory sites may have important implications in the pathogenesis of the post infectious complications seen in HIE such as bronchiectasis and bronchopleural fistula formation following pneumonia.